The role of cell, antigen, and antibody, in controlling virus infection through Fc-dependent mechanisms

Abstract
The ability of an�bodies to bind infected cells and ac�vate cellular immunity through an�body-dependent cellular
cytotoxicity (ADCC), an�body-dependent cellular phagocytosis (ADCP), and complement-dependent cytolysis (CDC) is
cri�cal to control of intracellular virus and intra-host dissemina�on. The induc�on of these responses is therefore highly
desirable in an�viral and immunotherapeu�c responses. However, our understanding of how to exploit ADCC/ADCP/CDC
signiﬁcantly lags that of neutralising ac�vity. Whereas neutralising an�bodies can be readily induced by vaccina�on with
entry glycoproteins or receptor-binding subdomains, it remains unclear how to select an�gens, domains, or epitopes, for
op�mal ADCC ac�vity. We have shown that there is litle correla�on between the ability of an�bodies to neutralise and to
ac�vate cellular immunity, and that previously unsuspected an�gens can induce signiﬁcantly enhanced Fc-dependent
ac�vity compared to those that induce neutralising responses. It is now cri�cal to understand why some an�gens and
epitopes oﬀer superior ac�va�on of cellular immunity. Our previous work required laborious wet-lab screening with ex
vivo cells, virus infected cells, and proteomics, to iden�fy op�mal targets for this ac�vity. Deciphering the underlying
biology of this process oﬀers the poten�al to predict ideal an�gens and to design epitope-speciﬁc vaccina�on strategies,
that maximise ADCC/ADCP/CDC responses in addi�on to neutralisa�on. This has the poten�al to enhance the eﬃcacy of
future vaccines and immunotherapies, as well as de-risk and accelerate their development.
Fc-dependent immunity requires eﬀector cell, an�body, epitope, and an�gen, to each co-ordinate. We therefore seek to
understand how each of these aspects contributes to eﬀec�ve control of intracellular virus. The molecular determinants
that govern how NK cells control virus dissemina�on through ADCC will be assessed func�onally and through high-
resolu�on imaging of the ADCC immunological synapse (IS), with proteomics used to determine why NK cells from diﬀerent
donors exhibit markedly diﬀerent ADCC capaci�es. Molecular engineering of an�bodies will inves�gate the speciﬁcity
requirements for ADCC responses, and methods of op�mising ADCC-inducing immunotherapies. Structural and IS-imaging
studies will reveal how an�gen structure and epitope conforma�on aﬀect ADCC eﬃcacy, and whether the same
requirements apply to the induc�on of ADCP and CDC. Finally, we will determine how predic�ons of Fc-dependent
immunity can be rapidly validated.
Although the way that these parameters interact is likely independent of any speciﬁc virus, viruses drama�cally remodel
the infected cell surface to counteract host immunity and this can signiﬁcantly alter the func�onal outcome of interac�ons.
We will therefore use two diﬀerent viruses throughout these studies – one which manipulates the surface proteome
extensively (HCMV), and one less so (SARS-CoV-2) – to reveal whether virus immune-evasion impacts outcome, and
whether any underlying principles are therefore virus-dependent. For both viruses we have iden�ﬁed novel an�gens and
monoclonals that provide enhanced ADCC responses as compared to current vaccine/immunotherapeu�c approaches.

Public health relevance
Project Narra�ve The ability of an�bodies to bind to cell-surface an�gen and ac�vate cellular immunity (e.g. through an�body-dependent cellular cytotoxicity; ADCC) is cri�cal in viral control, yet using mul�ple viruses (HCMV, SARS-CoV-2) we found that previously unsuspected an�gens can provide much greater ADCC responses than the an�gens that are usually used in vaccines and immunotherapies. However, we do not understand why these an�gens enable such superior ac�vity - addressing this knowledge gap will make it possible to predict how to induce potent ADCC and related mechanisms in next- genera�on vaccines. Being able to rapidly and easily ‘add’ these enhanced responses to an�viral strategies has the poten�al to improve the eﬃcacy and longevity of vaccines and immunotherapies, as well as their ability to maintain eﬃcacy despite rapid evolu�on of viruses, leading to a signiﬁcant reduc�on in the level of disease and harm caused by viruses in human popula�ons.